4/4 Asian Bipolar Genetics Network (A-BIG-NET)

PROJECT SUMMARY
Bipolar disorder (BP) is a severe multifactorial neuropsychiatric disorder that imposes a significant burden on
public health. The most recent large-scale genetic study of BP identified 64 associated genetic loci, providing
initial insights in BP pathogenesis. Yet, genetic discovery in BP lags behind other key psychiatric disorders. The
reported genetic loci only capture a small proportion of the total BP genetic liability, with many more variants
across the common and rare allele frequency spectrum remaining to be discovered. In addition, the previous
studied samples were of European ancestry, leaving population specific BP variants uncovered and uncertainty
in how the BP genetic findings generalize to other populations, exacerbating health disparities, and these studies
rarely employed “deep” phenotyping or assessed relevant environmental risk factors. This proposal brings
together an international collaboration of leading investigators from the U.S., Taiwan, South Korea, Singapore,
India, and Pakistan to form the Asian Bipolar Genetics Network (A-BIG-NET) and carry out a large-scale genetic
study of BP in East and South Asia. A-BIG-NET will generate a BP genetic resource of 27,500 cases and 16,000
controls with rich phenotypic information, measures of key environmental stressors and genetic data from 4x
low-pass whole genome sequencing (4xWGS). This will complement a schizophrenia genetics resource of
22,778 cases and 35,362 controls of Asian ancestry previously assembled by leaders of this network that will be
available for cross-disorder comparisons. Studying BP genetics in Asia is important to the world and the U.S.,
as Asia constitutes 57% of the world population, and Asian American comprises 6.6% of the U.S. population
(21.4 million). The five countries in A-BIG-NET cover 47% of all Asian populations. The specific aims of the
proposal are to: 1) recruit and deeply phenotype 17,500 BP cases, with a focus on BP-I to maximize homogeneity,
and 14,000 controls from four Asian countries; 2) carry out 4xWGS on all recruited samples plus 10,000 BP-I
cases and 2,000 controls collected by a previous study using similar procedures in Pakistan; and 3) carry out a
range of analyses to discover new genetic associations with BP-I across the allelic spectrum in East and South
Asian populations, examine the comparative genetic architecture of BP-I across major world populations and
with other major neuropsychiatric disorders, and perform a novel statistical fine-mapping analysis that leverages
the multi-ancestry genomic diversity and pleiotropy across psychiatric disorders to identify putative causal
variants. Aim 3 will also explore the genetic “validity” of various BP-I subtypes and fit models with joint genetic
and environmental risk factors. This proposal will dramatically increase the worldwide diversity of genetics data
on BP, an important step to accelerate gene discovery in this disorder and advance global mental health equity.

Public health relevance
PROJECT NARRATIVE This proposal will leverage the Asian Bipolar Genetics Network (A-BIG-NET), an international collaboration of investigators from the U.S., Taiwan, South Korea, Singapore, India and Pakistan, to carry out a molecular genetics study of bipolar disorder in East and South Asia. It will establish a valuable genetics resource with 4x low-pass whole genome sequence and rich phenotype data that will dramatically increase the worldwide diversity of genetics data on bipolar disorder, an important step to accelerate gene discovery in this disorder and advance global mental health equity.